Investigation of the Functional Roles of MicroRNA-320 in Skeletal Muscle

PROJECT SUMMARY/ABSTRACT
Disuse, denervation, and several diseases result in skeletal muscle atrophy and
weakness – a major contributor to disease-related disability and death. The mechanisms
underlying these processes are incompletely understood, and therapeutics are only emerging.
MicroRNAs are known to regulate many important cellular processes. We discovered
that in muscle developing weakness due to disuse (human) and denervation (mouse), there is a
marked reduction in microRNA320. Further, bioinformatic analysis demonstrates that FoxOs –
a group of transcription factors important in muscle degradation -- are potential targets of
miR320. Indeed, when we disrupted miR320 in cultured muscle cells, the FoxO pathway and
protein ubiquitination were upregulated. There is also evidence from others that miR320 may
have roles in skeletal muscle metabolism.
Given these findings, we created a muscle-specific knockout mouse (miR320mKO) to
explore the role of this miRNA in controlling skeletal muscle growth and maintenance in a long-
term, in vivo model. We have found that these mice develop severe muscle wasting over their
first 4 months of life.
This project will fully characterize the miR320mKO mice at the phenotypic level,
investigate the mechanisms by which this phenotype occurs, and carry out a pilot effort at
miR320 treatment in a model of mouse muscle atrophy. It promises to open up new avenues in
treatment of skeletal muscle disease.
Specifically, we will:
1. Characterize the phenotype of miR320mKO mice
-examine muscle size and microscopy, fiber size and type, muscle contractile force in
KO vs. controls; examine growth of proliferation and myotube formation of miR320mKO
primary muscle cell cultures
2. Investigate the mechanisms underlying the phenotype of miR320mKO mice
-dissect operant molecular signaling pathways and events using RNA sequencing;
identify potential targets of miR320 by miR-eCLIP and RNA sequencing, and confirm
those targets with 3’UTR luciferase reporters in C2C12 cells
3. Carry out a pilot treatment of skeletal muscle wasting with miR320 in mice
-study denervated limb muscle following delivery of miR320 via electroporation vs.
controls

Public health relevance
PROJECT NARRATIVE We have seen reduction of a molecule called miR320 in human muscle that is developing weakness due to disuse, and we showed that changes in miR320 has the potential to be causing this weakness. We have now created a knockout mouse with reduced amounts of miR320 in muscle. This project proposes to use this mouse, and other models, to investigate the role of miR320 in muscle growth and maintenance. The work promises to lead to new candidates for treatment of muscle wasting diseases.